22nd International Conference on Cytochrome P450: Biochemistry, Biophysics, and Biotechnology

The goal of this conference is to bring an interdisciplinary group of scientists from around the world whose research is focused on cytochromes P450 to provide networking opportunities, updates on cutting-edge technologies, opportunities for new collaborations, and to engage young scientists. These enzymes are responsible for a dazzling array of transformations in the disposition of xenobiotics and biosyntheses of hormones. Over 70% of drugs are metabolized by CYPs; hence tremendous resources are devoted to identification of substrates and inhibitors in drug development to avoid later attrition, or adverse drug interactions following introduction into the clinic. Accordingly, CYP research has positively impacted the fields of xenobiotic metabolism, endocrinology, toxicology, nutrition, and biotechnology. The ICCP450 series is the premiere meeting in the field, is small enough (~200-250 delegates) to facilitate interactions between delegates, but large enough to attract prominent speakers. The conference was last held in the United States in 2013 on the campus of the University of Washington in Seattle. ICCP450 2021 will be held at the Hyatt Regency Crystal City Hotel in Arlington, Virginia near Washington, D. C. from June 13-17, 2021. Nearby airports offer convenient access for both international and U. S. delegates. ICCP450 2021 will continue to focus on its traditional areas of strength, including advancements structural biology, novel biophysical methods, xenobiotic/endobiotic metabolism, and genetic control of P450 expression. However, additional goals of this meeting are to strengthen contributions from expert investigators that have adopted the powerful tools of metabolomics, synthetic biology, and high-performance computation. The meeting format facilitates interactions between trainees, junior and established investigators with representation from women and underrepresented minorities. The meeting will consist of a keynote lecture on Sunday (6/13) followed by twelve plenary lectures and more than 80 invited talks (6/14-17). There will be two posters sessions for scientists to present their work and participate in informal discussions. Some of the poster abstracts will be selected for short oral presentations. Here we request funds to support student travel awards (registration and lodging), plenary speaker registration, and production of electronic/printed materials.

Public health relevance
This application is for support for the 22nd International Conference on Cytochrome P450: Biochemistry, Biophysics, and Biotechnology (ICCP450 2021). This meeting provide the opportunity for established and emerging researchers from academia, industry and clinical medicine from around the world to come together to share their research on this fascinating group of enzymes. ICCP450 2021 will provide opportunities for professional networking, education about methodological advancements, establishing new collaborations, and engagement of young researchers.